Serotonin-mediated reorganization of the adolescent medial prefrontal cortex

Summary
Adolescence is associated with a high incidence of anxiety-related disorders, which often require lifelong
management. Anxiety disorders in adolescents are a leading cause of disabilities, as they negatively impact the
development of social, cognitive, emotional, and educational skills. The increased prevalence of anxiety
disorders during adolescence coincides with the suppression of fear extinction, an inhibitory learning that
attenuates conditioned fear memory. Consistently, cognitive behavioral therapy (CBT), which relies on the
principles of fear extinction, is effective in only a subset of affected adolescents. Recent studies show that a
combination of CBT and selective serotonin (5-hydroxytryptamine, 5HT) reuptake inhibitors (SSRIs) exhibits
superior effectiveness compared to either CBT or SSRIs alone in adolescents, suggesting a potential interaction
between 5HT signaling and fear extinction. However, little is known about how 5HT modulates the adolescent
ventromedial prefrontal cortex, a brain region that mediates the expression of fear extinction. Based on our recent
studies, the goal of this proposal is to determine whether and how enhancing 5HT transmission in the mouse
infralimbic medial prefrontal cortex (ILmPFC), a brain region analogous to the primate ventromedial prefrontal
cortex, during adolescence suppresses activity in ILmPFC somatostatin (SST) neurons and hence augments
ILmPFC-mediated top-down regulation of the amygdala and fear extinction in adolescents and adults. These
studies are particularly important as SST neuron-mediated inhibition in the ILmPFC is increased during
adolescence, and this development-dependent GABAergic plasticity overlaps with an attenuation of ILmPFC
pyramidal neuron plasticity and a suppression of fear extinction in adolescents. Our studies show that 5HT
enhances synaptic inhibition in ILmPFC SST neurons by acting on synapses from upstream 5HT3a receptor-
expressing neurons. We hypothesize that activating the ILmPFC 5HT transmission during adolescence
augments synaptic inhibition in ILmPFC SST neurons, leading to 1) a reduced inhibition of pyramidal neurons,
2) an augmentation of ILmPFC-mediated top-down regulation of the amygdala, and 3) an enhancement of fear
extinction in adolescents and adults. We will test this hypothesis by establishing whether activation of ILmPFC
5HT transmission during adolescence suppresses ILmPFC SST neuron activity and ILmPFC SST neuron-
mediated GABAergic transmission in adolescents and adults (Aim 1), enhances ILmPFC-mediated
glutamatergic transmission in the basomedial amygdala of adolescents and adults (Aim 2), and augments fear
extinction in adolescents and adults (Aim 3). The findings of this study are expected to provide critical
mechanistic insights into future evidence-based and developmentally tailored therapeutic approaches to
managing anxiety disorders in adolescents and adults.

Public health relevance
Narrative We will investigate whether activation of serotonin (5HT) transmission during adolescence enhances fear extinction in adolescents and adults by reorganizing synaptic inhibition in the infralimbic medial prefrontal cortex. These studies will significantly advance our understanding of how 5HT affects synaptic, cellular, and molecular mechanisms underlying fear extinction and will inform novel approaches for alleviating anxiety and fear-related disorders in adolescents and adults.